Inflammatory microenvironment in brain metastasis

Project Summary/Abstract
Breast cancer brain metastasis (BCBM) has emerged as a dominant clinical problem as treatments for peripheral
disease improve and patients live longer. The blood brain barrier creates a unique challenge as it restricts access
of most standard drugs to brain lesions, so median survival rates have remained stagnant at <2 years. Although
the immune system is a critical controller of metastatic spread in the periphery and the basis for many effective
new therapeutics, little is known about the immune response to BCBM. We have utilized single-cell RNA-
sequencing to investigate the response of microglia, the predominant immune effector in the central nervous
system (CNS), to BCBM. We find that microglia display a dramatic pro-inflammatory response to BCBM,
characterized by increased expression of a diverse array of chemokines and machinery for antigen presentation
through MHCI and MHCII, and that pharmacological depletion of microglia increases metastatic progression. We
will test the hypothesis that microglia play critical roles in suppressing BCBM through 1) chemokine-mediated
peripheral immune recruitment to initiate an inflammatory cascade, and 2) local antigen presentation to sustain
T cell activation in the CNS. This work will establish the basic mechanisms by which microglia control metastatic
outgrowth, how CNS immunity to BCBM develops and ultimately fails, and provide new insights for how to
therapeutically exploit the immune system to control BCBM in patients.

Public health relevance
Project Narrative Although the immune system has emerged as an effective therapeutic target to control tumor growth and metastasis of peripheral cancers, little is known about the immune response to breast cancer brain metastasis and why it ultimately fails to control CNS metastasis in breast cancer patients. We have utilized single-cell RNA-sequencing to find that microglia, the main immune cell populations of the CNS, display a dramatic and heterogeneous pro-inflammatory response to brain metastasis and are critical to suppress metastatic outgrowth in the CNS. In this study, we will determine the mechanisms underlying microglia-mediated metastasis suppression, by testing whether they are critical to recruit peripheral anti-tumor immunity and/or present antigen for local stimulation of T cell responses.